COMPARISON OF 2',3'-DDI GIVEN ORALLY 2/DAY TO PATIENTS WITH AIDS OR ARC

This study is designed to compare the efficacy and toxicity of zidovudine and Dideoxyinosine in patients with AIDS or ARC who have taken zidovudine for either a short period (less than two months) or a long period (more than 12 months) of time.